Network of the National Library of Medicine Evaluation Center

ABSTRACT
The Network of the National Library of Medicine Evaluation Center (NEC) will develop and enhance best-practice
evaluation strategies and resources for the benefit of the Network of the National Library of Medicine (NNLM).
The NEC will collaborate with NNLM and Regional Medical Libraries (RMLs) and Offices to develop standardized
processes and robust integrated visualization and reporting tools and data for evaluation and communication of
program activities and outcomes. We will assess the efficacy and outcomes of NNLM activities, services, and
resources, with a special focus on understanding its impact on persons who are underrepresented or experience
health disparities. Community and capacity building are made a priority through workforce and network
development activities and resources directed to the National Library of Medicine (NLM), Regional Medical
Libraries (RMLs), Offices, and Centers (ROCs), and network members. We will work with the NLM Office of
Engagement and Training (OET) and the NNLM Steering Committee (SC) to align this proposed work with the
NLM Strategic Plan and with emerging strategic priorities during the funding period. Through this opportunity,
we will support and advance NNLM’s mission “to advance the progress of medicine and improve the public's
health by providing U.S. researchers, health professionals, public health workforce, educators, and the public
with equal access to biomedical and health information resources and data.” We will accomplish this by
leveraging the unique culture, strengths, and capabilities of our team; empowerment approaches to build
capacity and community; integration of open processes and access, and a keen focus on understanding and
communicating outcomes and impact.

Public health relevance
NARRATIVE The Network of the National Library of Medicine Evaluation Center (NEC) will provide the Network of the National Library of Medicine (NNLM) with data-driven resources to support evaluation, continuous improvement, and communication of impact of programs and activities. Through this work, data, evaluation and software tools, and methods will be made openly available. These resources will be supported with community and capacity building initiatives to develop and sustain the use of evaluation to support and advance NNLM’s mission.